Next-Gen Oral Therapeutics for Concomitant Clostridioides difficile Infection and IBD

Next-Gen Oral Therapeutics for Concomitant Clostridioides difficile Infection and IBD
Biotherapeutics Inc (BTI) is an emerging biotech company that synergistically combines the power of advanced
computational modeling with translational experimentation to accelerate the development of novel products for
precision medicine and health.
Clostridioides difficile infection (CDI) affects almost half a million people in the U.S. yearly, causing 29,000 deaths
within 30 days of the initial diagnosis. CDI is trigged by gut microbiome disruption, commonly due to antibiotic
usage. However, the standard of care (SOC) is antibiotic-based therapy, leading to high recurrence rates. The
incidence of CDI is increased in inflammatory bowel disease (IBD) patients, and is the most common
complication in IBD, resulting in increased flares, mortality, and hospitalization days. Managing the treatment of
dual IBD and CDI is very challenging and there are limited therapeutic options. The goal of this SBIR Phase 1
application is to develop a novel, host-targeted, antibiotic-sparing oral therapeutic for dual CDI and IBD that
targets a novel mechanism of action with no-dose limiting toxicities. We will compare the therapeutic efficacy of
our novel drug candidate with FDA-approved therapeutics and determine the effects on the gut microbiome.
The Specific Aims of this SBIR Phase 1 are to:
AIM 1. Compare the efficacy of a novel oral immunoregulatory therapeutic candidate versus FDA-
approved treatments in concomitant CDI and IBD. We will use a DSS-induced and Helicobacter hepaticus
model of dual IBD and CDI to evaluate the comparative therapeutic efficacy of our new drug candidate to
vancomycin, gut microbiome transplantation (FMT) and anti-TcdB antibody. Endpoints will include mortality,
disease activity, weight loss, colonic histopathology and infiltration of inflammatory subsets.
AIM 2. Characterize the effects of a novel immunoregulatory therapeutic candidate in modulating gut
microbiome dynamics during CDI. Using the DSS-induced mouse model of IBD and CDI we will assess the
effects of our novel drug candidate in modulating gut microbiome composition and diversity, and the abundance
of C. difficile-resistant strains in comparison to vancomycin and anti-TcdB antibody. We will conduct 16S
sequencing, metabolomics analysis and targeted nutrient profiling.
Expected outcomes: i) ≥ 30% reduction in histopathological scores; and ii) ≥ 40% increase of alpha diversity;
compared to standard of care (SOC).
The SBIR Phase II will evaluate combination therapies with standard of care IBD therapeutics in additional
preclinical models, complete IND-enabling studies, and file an IND.
Commercial Application: This SBIR Phase 1 project will develop a novel anti-microbial free, host-centered oral
therapeutic for CDI treatment in IBD and non-IBD, for a market estimated to over $15 billion.

Public health relevance
Public Health Relevance Clostridioides difficile infection (CDI) is an opportunistic infection of the gastrointestinal tract (GI) that affects over 450,000 people annually in the U.S, with about 29,000 deaths within one month from the initial diagnosis. CDI is the most common complication in IBD and results in increased mortality rate, flare and worsening clinical outcomes. This SBIR Phase I application will develop a novel, oral, host-targeting, antimicrobial-free therapeutic that is safe and effective for the treatment of concomitant IBD and CDI.